Identification and characterization of FGF target genes

We are drafting a publication draft wherein we describe the defects that occur when we inactivate the FGF receptors (Fgfr1 and Fgfr2) in the presomitic mesoderm of the early mouse embryo. A prior impediment to this work was the difficulty in generating SC-RNA-seq data for these mutants, because a large number of embryos at the precise embryonic stage must be collected and genotyped. However, we have overcome this difficulty by using 10X Genomics (Chromium Single Cell Gene Expression Flex),which allowed us to generate RNA from single cells in embryos that we have fixed and frozen. The data we have generated is of high quality and we have confirmed much of the important changes in gene expression with HCR analysis. Our adaption of this technology serves as a model for other investigators in the community.